NEURAL AND HORMONAL INTERACTIONS DURING PUBERTY

The research project investigates the cellular basis for developmental shifts in responsiveness to endocrine and behavioral effects of testosterone during puberty in males. The hypotheses to be tested include: 1) whether changes in responsiveness to testosterone are mediated by quantitative changes in nuclear retention of steroid in target neurons or differential intraneuronal steroid metabolism; 2) whether the site of action of testosterone negative feedback on gonadotropin-releasing hormone secretion is at the level of neuronal cell bodies or terminals; and 3) whether endocrine and behavioral effects of testosterone are mediated by separate populations of steroid receptive neurons. The experiments employ steroid autoradiography, tract-tracing, immunocytochemistry, and combinations of these techniques.